Discovery of First-in-class WDR5 PROTACs as a Novel Therapeutic Strategy for MLL-rearranged Leukemias

Project Summary
This is an application for a Research Supplement to Promote Diversity in Health-Related Research (PA-21-071).
The parent R01 grant associated with this application is entitled “Discovery of First-in-class WDR5 PROTACs
as a Novel Therapeutic Strategy for MLL-rearranged Leukemias” and supported by the NCI
(1R01CA268384-01). Jerrel Catlett is the diversity candidate. He is a US citizen of African-American descent
and is currently an MD/PhD student at the Icahn School of Medicine at Mount Sinai, New York. In this project,
the candidate will conduct structural biology, biochemistry, biophysics and computational biology studies to
characterize PRORAC-induced WDR5-PROTAC-E3 ligase ternary complexes, and to provide new structural
insights for the PROTAC-induced ternary complex formation and guide design and development of more
effective WDR5 degraders.

Public health relevance
PROJECT NARRATIVE MLL-rearranged leukemia patients have a dismal prognosis and respond very poorly to standard treatments. The proposed studies will facilitate design and development of effective WDR5 degraders as a novel therapeutic strategy for the treatment of MLL-rearranged leukemias. Thus, the proposed research is directly relevant to public health.